Training in musculoskeletal research

The purpose and objectives of the training grant program proposed for continued support are to prepare
bioengineers for an academic career in orthopaedic research as part of a focused program leading to the Ph.D.
degree in Bioengineering. Training bioengineers in the same laboratory, side-by-side with orthopaedic
surgeons and life scientists at various levels of training, will continue to foster an environment conducive to
multidisciplinary research and education in the orthopaedic arena. Indeed, this has been the formula that we
have found very successful in our training program thus far. In today's complex and interdisciplinary research
world, this approach is more essential than ever. Trainee research areas represent a wide range of
musculoskeletal problems including, but not limited to, the cellular and molecular biology of bone growth,
repair, ossification, and maintenance; the etiology and pathogenesis of tendon and ligament injury, repair, and
regeneration; mechanical loading effects on articular cartilage; and biomaterials to promote tissue repair and
regeneration. In addition to formal didactic coursework outlined in our new Orthopaedic Bioengineering
curriculum, training opportunities include seminar series, journal clubs, and other enrichment activities.
The primary participating departments in this training program are the Department of Orthopaedic Surgery
in the Perelman School of Medicine and the Department of Bioengineering in the School of Engineering and
Applied Science at the University of Pennsylvania. Both departments have grown significantly over the past
five years in terms of numbers of faculty, grant funding, and trainees.
Four predoctoral trainees are requested in this continuation grant. It should be noted that the predoctoral
trainees work in a structured, yet flexible environment while completing course requirements toward the Ph.D.
degree in Bioengineering. Despite the fact that the Ph.D. program is typically five years in total duration,
typically, only two years, and not the first year, will be supported by this training grant so that positions can be
made available for new trainees to grow the program.
There are two primary training sites for this training grant. The first primary site is the McKay Orthopaedic
Research Laboratory in Stemmler Hall in the Department of Orthopaedic Surgery and the second is the
orthopaedic research unit in Skirkanich Hall in the Department of Bioengineering. These two facilities
represent >75% of the dedicated training space for the program. Finally, it should be noted that the University
of Pennsylvania operates a large number of state-of-the-art, sophisticated core facilities that are available to
faculty and trainees.

Public health relevance
The purpose and objectives of the training grant program proposed for continued support are to prepare bioengineers for an academic career in orthopaedic research as part of a focused program leading to the Ph.D. degree in Bioengineering. Training bioengineers in the same laboratory, side-by-side with orthopaedic surgeons and life scientists at various levels of training, will continue to foster an environment conducive to multidisciplinary research and education in the orthopaedic arena. Indeed, this has been the formula that we have found very successful in our training program thus far and, in today's complex and interdisciplinary research world, this approach is more essential than ever.